Structure and Function of Immune Gene Regulatory Networks

PROJECT SUMMARY
Gene regulatory networks (GRNs) are central to almost all biological processes. Research
in my laboratory focusses on understanding the structure and logic of human GRNs with the
ultimate goal of devising strategies for therapeutic interventions. Current gaps in our
understanding of GRNs include: determining how combinations of transcription factors (TFs)
regulate specific target gene expression patterns, identifying mechanisms by which different
genes are co-regulated to effect a given biological response, determining how GRNs are rewired
in response to environmental cues, and designing strategies to manipulate GRNs to modulate
biological outcomes. Cytokines present an ideal model system to study GRNs because cytokines
genes are highly regulated at the transcriptional level and because this regulation involves a
complex interplay between cell type-specific TFs and TFs activated by different signaling
pathways. In this proposal, we will investigate the structure and regulatory logic of the cytokine
GRN by integrating complementary methods to map protein-DNA interactions, functional
perturbations, and phenotypic characterizations. Further, we will determine the mechanisms by
which virally-encoded TFs perturb the cytokine GRN by determining the targeted cytokine
regulatory regions and targeted host proteins such as TFs, cofactors, and signaling proteins.
Overall, the proposed studies will identify general principles and generate a framework to study
and manipulate GRNs which will ultimately lead to novel strategies impacting human health.

Public health relevance
PROJECT NARRATIVE Proper gene expression is central for immune cell differentiation, homeostasis, and the response to external cues. The goal of the proposed research is to determine the rules governing the regulation of immune genes in healthy and pathogenic conditions. The findings and principles uncovered by these studies will lay a foundation for the design of novel therapeutic strategies.